FY23 TASK ORDER H - 126361 WEDGEWOOD SUITE M & N EXPANSION

Suites H and K at 4600 Wedgewood Boulevard houses the NCI-F Central
Repository. LBR has finalized leases with the landlord to secure the adjacent
suites M and N and expand the Central Repository to these areas. This project
will expand the Wedgewood Central Repository operations currently in Suites
H and K into the adjacent Suites M and Suite N. Suites M and N are currently
office and warehouse space, requiring the suites to be fully gutted and rebuilt.